Novel Immunotherapy Targeting Local and Systemic Immunity for Treatment of Ocular Surface Squamous Neoplasia

Project Summary
Ocular surface squamous neoplasia (OSSN) is a progressive ocular cancer that lacks approved treatments and
is increasing in prevalence globally. We have developed a new liposomal-TLR agonist immunotherapy (LTAC)
that in a novel equine spontaneous OSSN model effectively induces OSSN resolution following topical and
perilesional administration in most treated animals. We now propose to use the equine OSSN model to
elucidate immunological mechanisms underlying the antitumor activity of LTAC immunotherapy. In Aim 1,
local immune responses will be investigated using tumor biopsy and corneal swab samples, including
immunohistochemistry and transcriptomic analysis. These studies will identify immune correlates with
responsiveness and resistance to immunotherapy. In Aim 2 we will determine whether LTAC immunotherapy
also induces systemic immunity to OSSN, using OSSN antigen-specific T cell and antibody assays. These
studies overall will advance the field of ocular immunotherapy for ocular cancers and provide important new
insights into local and systemic OSSN immunity.

Public health relevance
Relevance to Public Health. Ocular surface neoplasia (OSSN) can cause permanent corneal injury and blindness and there are no FDA approved treatments for OSSN. Multiple different off- label treatments are currently used, some with significant side effects. In this proposal, we will evaluate a new type of ocular immunotherapy for OSSN, which we have shown induces tumor regression in a horse OSSN model, and conduct studies to better understand the mechanisms of how this new immunotherapy works to help advance this treatment for patients with OSSN.